ANIMAL MODEL DEVELOPMENT AND BEHAVIORAL ASSESSMENT (AMD-BA) CORE

The Molecular and Cellular Geroscience CoBRE is designed to facilitate interdisciplinary Geroscience
research on the OUHSC campus with the goal of developing a systematic understanding of the mechanistic
links between aging and chronic disease. All the Projects in this CoBRE will use mouse models as their
primary experimental platform to address the interaction between aging and the development of chronic
age-related diseases. The primary objective of this Animal Model Development and Behavioral
Assessment (AMD-BA) Core is to provide resources, assistance and training for 1) behavioral assessment
and gait/mobility analyses, and 2) development, maintenance and phenotyping of animal models of aging
and age-related chronic diseases, supporting the overall functions of the CoBRE, in a unified fashion that
is not possible via other current resources. The core provides highly innovative resources for analysis of
cognitive function and gait analysis. Additionally, these services will remove barriers to research that have
prevented basic scientists studying age-related disease from expanding their research to Geroscience.
The Core is composed of two basic components: Behavioral Assessment and Gait/Mobility Analysis and
Animal Models. The specific aims are to: 1. Provide access to sophisticated state-of-the-art Specific
Pathogen Free (SPF) behavioral testing facilities that allow investigators to characterize cognition and
gait/mobility in animal models of aging and age-related chronic diseases. At the same time the goal is to
improve current experimental paradigms and develop new procedures to enhance the efficiency and
accuracy of behavioral assessments in mouse models of aging and develop novel approaches for data
analysis. The AMD-BA Core will provide training for investigators and their staff in behavioral assay
procedures and the use of behavior-al testing equipment as well. 2. Provide access to animal models of
aging and coordinate the sharing of tissues derived from animal models of aging and manage the
Geroscience animal model tissue bank. The AMD-BA Core is a unique research facility in Oklahoma. It will
provide support for the PJIs in this application and pilot projects funded by the CoBRE. This Core service
will greatly enhance Geroscience research in Oklahoma and contribute to further growth of the Geroscience
Program.